HIV Center for Clinical and Behavioral Studies

Strong and effective leadership is required for promotion of new and innovative science, and is critical to
forging the new scientific and community partnerships needed to address emerging research challenges in
HIV/AIDS prevention, treatment, and care. The Administrative Core draws on a multi-disciplinary team of
senior researchers and administrators to set, implement, and evaluate the HIV Center's scientific agenda and
ensure efficient administrative and fiscal coordination of our domestic and international research projects. The
Core serves as the hub for Center activities and coordination across the Cores and as a liaison between the
Center and internal and external affiliated entities that inform and collaborate in our research agenda. Core
leadership will ensure the Center maintains its focus on our Center's chosen theme “The Science of Ending the
HIV/AIDS Epidemic (EtE): Efficacy to Effectiveness at Scale,” and its emphasis on implementation research
and research at the intersection of biomedical and behavioral and social science. The Core has three Specific
Aims: (1) to provide scientific and programmatic leadership and governance that positions the HIV Center as a
local, national, and international resource; (2) to ensure synergy and scientific rigor of the HIV Center and its
Cores in meeting the Center's short-term and long-term goals; and (3) to provide centralized administration
and coordination of fiscal and organizational management of HIV Center Cores and affiliated research projects.
We will accomplish our Aims through a range of mechanisms that include (1) internal monitoring of day-to-
day operations and Cores' and investigators' progress, through ongoing Center leadership meetings and also
Center and Core leadership meetings; (2) working with several external groups to support the Center in
evaluating and updating short-term and long-term strategic planning goals, including (a) our Strategic Planning
Group, comprised of scientific and community leaders in the field, (b) four Community Advisory Groups, in
collaboration with the NYC and NYS Departments of Health, (c) our mandated team of Scientific Advisors, and
(d) our innovative Performance and Safety Monitoring Board; (3) supporting a range of communication and
dissemination activities, including (a) maintaining a dynamic re-designed Website; (b) providing technical
support for e-updates, listservs, wikis, and web-based conferencing; (c) distributing a monthly electronic
newsletter; and (4) providing administrative and fiscal management for all grant-related activities. The
Administrative Core will be led by current Center Director Robert H. Remien, Ph.D., a Professor of Clinical
Psychology in Psychiatry at Columbia University, supported by current Center Co-Director Claude Ann Mellins,
Ph.D., a Professor of Clinical Psychology in the Departments of Psychiatry and Sociomedical Sciences at
Columbia University; a new Center Co-Director Gina Wingood, Sc.D., M.P.H., a Professor of Public Health
Promotion in Sociomedical Sciences at the Columbia University Mailman School of Public Health; and Masud
Rahman, M.S., M.B.A., current Center Director of Finance and Administration.